Elucidating the Neurocircuitry of Irritability with Ultra-High-Field Neuroimaging to Identify Novel Therapeutic Targets

PROJECT SUMMARY/ABSTRACT
With this Mentored Patient-Oriented Research Career Development Award, the candidate – a psychiatrist with
strong background in clinical research – aspires to achieve the long-term goal of becoming an independent,
federally funded investigator who (i) uses a neuroscience-informed experimental medicine approach to identify
neurocircuit mechanisms and (ii) conducts clinical trials to develop the next generation of circuit-specific antide-
pressant treatments in order to ameliorate the public health burden of irritability, an important yet understud-
ied feature of depression that is associated with poorer quality of life and elevated levels of suicidal ideation.
Candidate proposes structured research experience and formal training in (1) ultra-high-field [7 Testa (7T)] func-
tional magnetic resonance imaging (fMRI), (2) the affective neuroscience of irritability [including the use of task-
based fMRI to model frustrative nonreward (FNR), an evolutionarily conserved response to omission of an ex-
pected reward], and (3) experimental therapeutics approach to conduct clinical trials with changes in neurocircuit
function as the outcome measure of interest, that will be supervised by a team of prominent experts in neuroim-
aging, psychiatric neuroscience and experimental therapeutics. To fill the knowledge gaps regarding the neu-
rocircuit mechanisms of irritability, candidate’s proposed research strategy aims to identify dysfunctions in neu-
rocircuitry that engender irritability (Aim 1) and determine how changes in neurocircuit function relate to changes
in irritability (Aim 2). The proposed study will enroll male and female adults aged 18-55 years [n=30 healthy
controls (HC) and n=60 adults with major depressive disorder (MDD)]. All subjects will undergo resting-state and
task-based 7T fMRI to characterize the (i) patterns of functional connectivity (Aim 1.1) and (ii) neural responses
to a behavioral task of FNR (Aim 1.2) that are associated with irritability (quantified with the 5-item irritability
domain of Concise Associated Symptom Tracking scale). The MDD cohort (n=60) will then be randomized to 2
weeks of twice-weekly intravenous infusions of either ketamine (0.5 mg/kg) or midazolam (0.02 mg/kg) in a
double-blind parallel-arm fashion. Clinical assessments and MRI scans will be repeated after the last infusion to
evaluate pre-to-post treatment changes in neurocircuit function using resting-state (Aim 2.1) and FNR (Aim 2.2)
task-based fMRI with ketamine versus midazolam and to explore the association between changes in neurocir-
cuit function and irritability. Candidate’s didactic and mentored training in 7T fMRI, affective neuroscience, and
experimental therapeutic approach will enable successful execution of the research strategy. Research activities,
such as collecting, storing, analyzing, and interpreting data from MRI scans and from clinical assessments, will
provide valuable hands-on training. Successful completion of the proposed study will allow candidate to (1) ac-
quire expertise in the conduct of neuroscience-informed studies that use experimental therapeutics approach
and (2) generate pilot data in order to pursue NIH funding and build this highly innovative program of research.

Public health relevance
PROJECT NARRATIVE Poorly understood biological mechanisms of irritability – a feature of depression in 40-50% of adults with major depressive disorder (MDD) that is associated with poorer quality of life, more chronic course of illness, and elevated suicidal ideation – have hindered our efforts to develop novel treatments. We propose to study healthy individuals and adults with MDD in order to understand how irritability is associated with aberrant function of key brain regions at the neurocircuit level, and to identify changes in neurocircuit function that are specific to pharmacological treatment-related improvements in irritability. A better understanding of these neurocircuit mechanisms will facilitate our development of targeted treatment strategies that will reduce the suffering of indi- viduals with MDD and other mental illnesses with burdensome irritability, such as disruptive mood dysregulation disorder, generalized anxiety disorder, bipolar disorder, post-traumatic stress disorder, and borderline personal- ity disorder.